MyGI Diet for Colorectal Cancer Prevention

PROJECT SUMMARY
Despite the large body of research that has identified the impact of diet on cancer risk, little has been done to
translate these findings to clinical settings. Here we address prevention of colorectal cancer (CRC), the third
most prevalent cancer in the U.S. CRC is among the cancers that are most strongly affected by diet and excess
adiposity, and incidence is increasing in young people below the age of 40. More efforts need to be directed at
providing individuals with the tools needed for achieving and maintaining a preventive diet. Recommendations
for cancer prevention from the American Cancer Society and American Institute for Cancer Research include
advice to maintain a healthy weight, to consume more plant-based foods, and to limit red meats, processed
meats, and foods with added sugar. This proposal addresses the development of methods that could feasibly
be implemented in medical settings to assist high risk individuals in attaining both the weight management and
diet quality goals for prevention of CRC. Building on our previous trials, this proposal seeks to test two dietary
interventions in overweight and obese persons who have a strong family history of CRC or a personal history of
CRC. We will recruit 240 participants who will be randomized to receive to 12 months of: 1) a control group that
receives written information on preventive diets; 2) a Western Limit Diet that simply encourages limiting foods
associated with increased risk of CRC: ultra-processed foods (foods containing refined flour, added sugars, or
processed meats) and red meats; or 3) a Comprehensive Diet that combines goals for both limiting Western
foods and consuming preventive foods. The two interventions will be supported by written educational materials,
brief telephone contacts by case managers, and a different module of the MyGI app for each diet. MyGI
incorporates checklists to facilitate real-time goal tracking, tailored messaging, and real-time display of progress
made. The dietary changes are expected to improve diet quality and achieve a sustainable, slow rate of weight
loss over time that appears to be more favorable for cancer prevention than conventional obesity treatment. The
specific aims are: 1) To determine if an intervention limiting Western foods has similar effects as a
Comprehensive intervention, versus Control, on the dual primary outcomes of improving diet and achieving
modest weight loss in overweight and obese subjects at increased risk of CRC. Secondary outcomes include
biological and behavioral measures of intervention adherence, app usability, and serum markers of inflammatory
stress. 2) To evaluate whether skin carotenoids (as a biomarker of fruit and vegetables consumption) and breath
ketones (as a biomarker of fat oxidation) can be utilized as non-invasive, objective measures of dietary
compliance. The long-term goal is to identify an intervention that could be incorporated as part of usual health
maintenance care to help high risk patients meet and maintain dietary cancer prevention goals.

Public health relevance
NARRATIVE This project seeks to change how health maintenance care is provided in medical settings by identifying a feasible method that could help patients at increased risk of colorectal cancer meet and maintain a preventive diet. The study tests two different app-based dietary approaches, versus control, to determine which is optimal for meeting the diet quality and weight management goals that are recommended for cancer prevention. The project also evaluates methods that feasibly could be used in a primary care setting to non-invasively monitor diet and energy balance as a means to track and reinforce each patients’ progress towards achieving a preventive diet.